A low-cost benchtop oligonucleotide synthesizer using inkjet enzymatic DNA synthesis

ABSTRACT
The objective of this proposal is to develop a benchtop, inkjet-based, oligonucleotide synthesizer
using aqueous, enzymatic DNA synthesis technologies for the parallel synthesis of up to 1 million
high-quality oligonucleotides per day. The system will deliver >10-fold improvements in the key
metrics of cost, quality, and throughput compared to existing technologies. The synthesis
biochemistry will utilize engineered terminal deoxynucleotidyl transferase enzymes that have
been optimized for incorporation of 3’ aminoxy reversible terminator nucleotides. This approach
has several advantages, including proven performance in the synthesis of oligonucleotides up to
300 nucleotides on microbeads. Here, we will adapt the technology to enable DNA synthesis on
functionalized microscope slides using inkjets for precise reagent delivery. A multidisciplinary
approach will be followed to advance toward the goals in terms of engineering for instrumentation
development, biochemistry and protocol optimization, and performance benchmarking of the
synthesized oligonucleotides. During the first year, we will build an initial testbed to enable
verification and optimization of individual components, materials, reagents, and protocols. In the
second year, we will build a fully automated prototype instrument, and refine the protocols and
software to allow synthesis of long oligonucleotides. Finally, Year-3, we will build multiple
benchtop instruments and work with partner laboratories to test the oligonucleotides in several
‘real world’ applications. Subsequent commercialization of the instruments will democratize
access to rapid high-density oligonucleotide synthesis, and revolutionize approaches to a wide
variety of synthetic biology and functional genomics applications.

Public health relevance
Project Narrative This project will develop a novel enzymatic DNA synthesis technology to enable the rapid synthesis of high-quality DNA for use in a wide variety of applications. It will include the development of a benchtop DNA printer, and testing of the instrument in partner laboratories. This DNA-on-demand technology promises to revolutionize approaches to synthetic genomics, functional biology, and a wide variety of other applications in biotechnology and biomedical research.